NUTRITIION PRACTICE GUIDELINES FOR GESTATIONAL DIABETES

The purpose of this study is to compare two types of nutrition care provided to women with gestational diabetes (GDM) by registered dietitians. The study will answer the question: Does nutrition care delivered according to new nutrition practice guidelines result in better pregnancy outcomes than usual nutrition care delivered according to new practice guidelines provided by registered dietitians?